Training the next generation of leaders in biomedical engineering design

Project Summary/Abstract
The next generation of bioengineering and biomedical researchers will have unprecedented access to
technologies including wireless health, big data, genetic sequencing, and machine learning approaches to
enable modern diagnostic and therapeutic techniques. This presents individuals trained at the interface of
technology and biomedicine with an enormous opportunity to address the world’s needs in health and
medicine. In the Bioengineering Department at the University of California, Los Angeles, we aim to develop
students into leaders able to seamlessly identify clinical needs that technology can address, design and
validate solutions that address these needs, communicate with a variety of stakeholders to build teams
invested in problem-oriented solutions, and to navigate the regulatory and commercial pathways necessary
to enable their technologies to thrive.
The Bioengineering Capstone Series at UCLA leverages resources available at UCLA to enable students to: 1)
gain insight into clinical needs directly from clinicians and educators across the Ronald Reagan Medical
Center, David Geffen School of Medicine, School of Dentistry and UCLA Health System, 2) design their
solutions through mentorship from engineering professors, 3) understand the complexities of the biomedical
industry with support from the UCLA Technology Development Group and members of the Department of
Engineering Industry Advisory Board, 4) utilize modern technologies in wireless health and data science by
collaborating with the Center of Excellence for Mobile Sensor Data- to-Knowledge (MD2K) and Mobile Health
(mHealth) Institute at UCLA, and 5) work with the National Science Foundation Precise Advanced
Technologies and Health Systems for Underserved Populations Engineering Research Center (NSF PATHS-
UP ERC) to learn to target and communicate their technologies to maximize societal benefits.

Public health relevance
Statement of Public Health Relevance: To prepare the next generation of engineers with skills in the design of therapeutics and medical devices, this research education program will provide bioengineering students at UCLA with enhanced opportunities to engage in real world design for biomedical applications. We will guide students through the medical design process from identifying needs, creating solutions which address these needs, and communicating the significance of their contributions to the greater community, ultimately yielding a larger pool of well-trained engineers to address biomedical challenges. !